Developmental Research Program

The goals of the Developmental Research Program (DRP) of the MSK Pancreas SPORE are to expand the breadth of the translational pancreatic cancer research base and to encourage highly innovative investigations that have major potential to impact pancreatic cancer outcomes. DRP funds, supplemented by institutional funds, will allow us to support 2 exceptional pilot projects each year. We will request proposals for pilot projects with a clear translational focus and with potential to ultimately impact clinical care of patients with pancreatic neoplasms. Investigators (MD, MD/PhD, DO, or PhD) with a demonstrated history of pancreas cancer research appointed at MSK or a neighboring institution, Weill Cornell Medical College and the Rockefeller University, will be eligible to apply. Applications will be peer-reviewed by the CEP/DRP Selection Committee, which is composed of the SPORE PIs, DRP and CEP Leaders, as well as select MSK Departmental and Divisional Chairs. The most meritorious projects based on defined review criteria will be selected. Preference will be given to projects that advance the long-term research goals of the SPORE and have high potential to become full SPORE projects DRP awardees will have full access to SPORE Core resources, will benefit from the expertise of the SPORE investigative team, and will be active participants in the SPORE. The scientific progress of DRP projects will be evaluated every six months by the DRP Leaders. Long-term metrics of success for DRP awardees include presentation/publication of original research, successful competition for independent research support, successful development and completion of clinical trials stemming from DRP research, establishment of new collaborations, and institutional recognition by academic promotion. DRP projects that make significant progress towards their translational goals will be eligible for a second year of funding and have the potential to be promoted to full SPORE projects.

Public health relevance
NARRATIVE Not applicable.